REGULATORY AFFAIRS CONSULTANT SUPPORT SERVICES

Regulatory affairs support for the development of biologics therapies for central nervous system disorders.

Public health relevance
Regulatory affairs support for the development of biologics therapies for central nervous system disorders.